Gut microbiota dynamics, exercise and physical function among older people with HIV

PROJECT SUMMARY.
Novel strategies are urgently needed to enhance the efficacy of exercise in improving physical function of older
people with HIV (PWH). Our team has identified impairments in measures of physical function across several
cohorts of middle-aged and older PWH. Exercise is the standard of care for prevention and treatment of impaired
physical function in people without HIV, and we previously demonstrated that exercise also improves physical
function in older PWH; however, the effectiveness of responses varied. The gut microbiome plays a pivotal role
in the regulation of gut health, and exercise has been associated with changes in the gut microbiome and
improvements in physical function measures in people without HIV, yet little is known in regards to the gut
microbial features associated with an exercise-gut microbiome-physical function axis in older PWH. HIV-1-
associated disruption of the gastrointestinal tract is characterized by perturbations in gut microbiota (dysbiosis),
epithelial barrier breakdown and microbial translocation which, in turn, has been linked to systemic inflammation
and the development of multiple age-associated co-morbidities. In our prior studies of older adults with and
without HIV, we established that relationships between the gut microbiome and relevant outcomes (systemic
inflammation, physical function) differ based on HIV serostatus. Moreover, systemic levels of intestinal fatty acid
binding protein (IFABP), a biomarker indicative of gut epithelial barrier damage, were reduced in older PWH
following an exercise intervention. In preliminary studies, we found that in older PWH, higher levels of myostatin,
a muscle biomarker associated with the negative regulation of skeletal muscle growth, significantly associated
with higher systemic levels of IFABP, and myostatin levels were reduced following a supervised exercise
intervention. Similar observations were not observed in people without HIV. Taken together, our observations
suggest a unique exercise-gut microbiome-physical function axis also exists in older PWH. The central
hypothesis of this proposal is that a supervised exercise intervention will lead to changes in the gut microbiome
of older PWH with associated improvements in gut epithelial barrier integrity and reduced microbial translocation,
ultimately resulting in improved muscle function and physical function outcomes. These ‘health-positive’ changes
in the microbiome will be observed to a lesser extent (if at all) in participants with limited improvements in physical
function. We propose to determine the impact of a 16 week supervised exercise intervention on the structure
and function of fecal microbial communities in older PWH with viral suppression (Aim 1), and to identify microbial
and metabolomic features associated with epithelial barrier damage, microbial translocation and muscle health
(Aim 2), and with physical function outcomes (Aim 3). Identification of specific gut microbiome features will
provide the groundwork for the effective design of future therapeutic trials that enhance the efficacy of exercise
in improving physical function of older PWH.

Public health relevance
Narrative. The goal of this study is to identify gut microbial features within the exercise-physical function axis of older people with HIV (PWH), and to address the potential role for the gut microbiome in the heterogeneity of exercise- associated improvements in physical function. Identification of specific gut microbiome features will provide the groundwork for the effective design of future therapeutic trials that enhance the efficacy of exercise in improving physical function of older PWH.